Unravelling Mechanisms and Novel Therapeutic Targets for Peripheral Neuropathy and Neuropathic Pain (Diversity Supplement)

Title: Unravelling mechanisms and novel therapeutic targets for peripheral neuropathy and neuropathic pain
Abstract
Damage to or loss of the peripheral axons of primary sensory neurons is associated with two clinical
syndromes: peripheral neuropathic pain and peripheral neuropathy. Treatment for neuropathic pain is typically
ineffective or associated with side effects, and there is no treatment for peripheral neuropathy. To remedy this,
it is essential that the mechanisms responsible for both are understood and targets identified that could be
amenable to development of novel therapeutics. My goal is to dissect out at an individual neuron level the
transcriptional and functional changes that occur over time in response to physical axonal injury, ion channel
mutations and exposure to neurotoxic cancer chemotherapeutic agents, and explore the extent to which
hyperexcitability and axon degeneration are linked. This will involve combinations of several different
approaches: correlating single cell profiles and disease related functional changes, identifying disease
susceptibility in patient stem derived neurons, high content phenotypic screens, population imaging in intact
animals, genetic editing, and interrogation at high temporal and spatial resolution of behavioral surrogates of
pain and sensory loss. The project will focus on neuropathic pain due to physical disruption of peripheral
sensory axons, small fiber neuropathies due to voltage-gated sodium channel mutations and chemotherapy-
induced peripheral neuropathy, and will examine if these syndromes are distinct or part of a spectrum of
sensory neuron pathologies with overlapping risk factors and mechanisms.

Public health relevance
Narrative This project is designed to identify the molecular and cellular changes that occur in sensory neurons after axonal injury and establish how these drive neuropathic pain and the evolution of peripheral neuropathy, exploring the extent to which these two syndromes are distinct or linked, and identifying opportunities for new therapeutic intervention.